Trauma Socialization as a Cross-Cutting Risk Factor for Violence Perpetration and Victimization

PROJECT SUMMARY
Early-life exposure to intimate partner violence (IPV) is a risk factor for later violence perpetration and
victimization. Maladaptive mental health outcomes that arise as a result of IPV exposure are a large driver of
this relationship. Yet, there are still major gaps in knowledge about how modifiable processes link IPV exposure
with these outcomes. Better understanding this relationship will lead to more effective interventions for young,
IPV-exposed children, which may subsequently prevent future self-directed violence, youth violence, and teen
dating violence among US youth.
The proposed Mentored Research Scientist Career Development Award will train the candidate in conducting
community-based research on how modifiable parent processes contribute to IPV-exposed children’s mental
health outcomes and physiological dysregulation. The candidate’s current skill set includes intervention
adaptation and evaluation, the assessment of violence-related psychopathology, and multivariate statistics and
longitudinal modeling. Through the current award, the candidate seeks advanced training in: 1) physiological
assessment of stress responses in violence-exposed young children, 2) community-based research methods,
and 3) dyadic data analysis. The candidate’s mentoring team: Levendosky, Perry-Jenkins, Deater-Deckard,
Karatsoreos, Meyer, Powers, and Laws, provide expertise in: assessing IPV and its effects; neuroendocrine and
immune system stress responses; community-based research methods; and dyadic family process and data
analysis. The long-term goal of this training is to develop a translational program of research aimed at reducing
lifetime violence exposure by more effectively ameliorating the negative effects of early-life IPV exposure.
The proposed study will examine how caregiver communication (direct and indirect) about trauma, danger, and
fear – termed, trauma socialization – relates to young children’s adjustment and physiological dysregulation in
the context of IPV. Children ages 4-5 years (N = 125) with a history of early-life IPV exposure will be recruited
from the diverse city of Springfield, MA and the surrounding metropolitan region. Trauma socialization will be
assessed using a novel storytelling task that has caregivers and children read a book that deals with themes
related to child trauma and fear. Caregiver behavior, affect, and verbalizations will be coded to assess the extent
to which trauma socialization is regulated or dysregulated. Child mental health and physiological dysregulation
will then be assessed via established methods. The proposed study is designed to focus on a novel, trauma-
specific parenting process, and ultimately identify potential mechanisms by which IPV exposure leads to adaptive
or maladaptive adjustment to prompt novel violence prevention strategies.

Public health relevance
PROJECT NARRATIVE Early-life exposure to intimate partner violence (IPV) puts children at risk for future violence victimization and perpetration through its effects on mental health outcomes. Trauma socialization (TS) – or the processes by which caregivers communicate information and perspectives about trauma, danger, and fear – is one modifiable process that may shape children’s pathways to risk for future violence involvement. The proposed study examines the effects of TS on children’s early symptoms of aggression, PTSD, and internalizing problems; as well as the effects of TS on children’s physiological stress regulation.